Mechanisms of maternal brain changes with birth interventions

PROJECT SUMMARY
Nearly one in three births in the United States occurs after a labor induced with exogenous oxytocin, yet
surprisingly little is known about the long-term consequences of this birth intervention for maternal health.
Research indicates a link between labor induction and increased risk for experiencing postpartum hemorrhage,
the leading cause of maternal mortality worldwide. Notably, incidence of severe postpartum hemorrhage has
risen over the past decade. Labor induction has also been linked to increased risk for postpartum depression.
Nearly one in five mothers will be diagnosed with postpartum depression, a serious mental health condition that
can lead to decreased quality of life for mothers and disrupted mother-infant interactions and caregiving. Despite
the rising rates of severe postpartum hemorrhage and the high prevalence of postpartum depression, little is
known about factors that increase risk for these outcomes. For some women, changes to the oxytocin system
may increase risk for postpartum hemorrhage and postpartum depression, including epigenetic modification of
the oxytocin receptor gene, OXTR. Interestingly, OXTR genotype interacts with the methylation state of the gene
to increase risk for these adverse outcomes. The common link between labor induction, postpartum hemorrhage
risk, and postpartum depression risk may well be altered functioning of the oxytocin system. The prairie vole, a
model of birth and labor intervention, has a polymorphism within Oxtr that naturally alters expression of a novel,
unstudied Oxtr transcript (OxtrH). During the previous funding period, the changing epigenetic and transcriptional
state of Oxtr was mapped across gestation, birth, and postpartum in mothers; it was discovered that variability
in OxtrH expression is associated with differential response to exogenous oxytocin given just prior to birth and
impacts the DNA methylation state of Oxtr and transcriptional response to birth. This proposal aims to: (1)
understand the role of the OxtrH transcript in epigenetic regulation of Oxtr and expression of its alternative
transcripts in natural, unmanipulated vaginal birth, (2) understand the ways labor induction with exogenous
oxytocin alters how OxtrH shapes the DNA methylation and transcriptional state of Oxtr, (3) assess the influence
of the OxtrH transcript on regulation of gene expression across the maternal transcriptome, and (4) determine
the impact of OxtrH on maternal behavior. The experiments in this proposal will provide valuable information on
how natural birth and labor induction, a very common birth intervention, differentially shape development of the
DNA methylation state of the maternal uterus and brain and how genotype can influence the molecular outcomes
of the state of Oxtr in mothers postpartum. The goal is to model and functionally characterize risk factors for non-
optimal outcomes in some women and, ultimately, develop interventions to counter those risk factors and improve
maternal health.

Public health relevance
PROJECT NARRATIVE The use of exogenous oxytocin to induce or augment labor has risen dramatically over the last three decades, yet little is known regarding the long-term consequences for the mother and how this birth intervention impacts the endogenous oxytocinergic system in the peripartum period and beyond. Labor induction with exogenous oxytocin is associated with increased risk for postpartum depression and postpartum hemorrhage in new mothers, particularly in specific genetic backgrounds, and both conditions are associated with dysfunction in the oxytocinergic system. We will investigate the impact of birth and use of exogenous oxytocin during birth in a proposed risk genetic background to establish its effects on the epigenetic regulation of OXTR and function of the oxytocinergic system - we will uncover essential information on how giving birth shapes the maternal oxytocinergic system and how naturally occurring variability within this system influences sensitivity to oxytocin in the peripartum period, potentially contributing to adverse maternal health outcomes.